Long Lasting Organic Semiochemical Formulation to Effectively Manage Blood Sucking Diptera.

Project Summary:
SPLAT BAC Plus is a unique controlled-release larvicide designed to suppress populations of multiple species of
mosquitoes, such as those that transmit malaria, dengue, and West Nile virus (WNV). This CRP proposal seeks
to establish SPLAT BAC Plus as an effective, economically viable control strategy for use in integrated vector
management (IVM) programs and for control of nuisance mosquitoes around the globe. SPLAT BAC Plus has
several advantages over previous larvicides: 1) It contains a combination of larvicidal agents with different modes
of action: Bacillus thuringiensis israelensis (Bti), B. sphaericus (Bsp) [recently renamed Lysinibacillus
sphaericus]—two bacteria that destroy the gut of mosquitoes that ingest them—and an insect growth regulator
(IGR), such as methoprene or pyriproxyfen, that prevents larvae from developing into adults. This combination
drastically reduces the risk of resistance compared to single-action larvicides. While there are products on the
market combining Bti and Bsp, the inclusion of an IGR in SPLAT BAC Plus will further inhibit the development
of resistance and greatly extend the field life of the larvicide. 2) SPLAT BAC Plus includes components that
promote larval attraction and feeding on the formulation—intensifying their exposure to the Bti, Bsp, and IGR
contained within it—and oviposition attractants (attractants for egg-laying females). As point sources of SPLAT
BAC Plus float at the surface of treated water, these attractants are released into the air, enticing female
mosquitoes to lay their eggs preferentially at that site. 3) SPLAT BAC Plus can be applied to potential larval
habitats under dry conditions ahead of rainfall, a major advantage over most larvicides, which must be applied
shortly after these sites fill with water to catch mosquito larvae at a susceptible stage. 4) Following application,
SPLAT BAC Plus cures and becomes rainfast, becoming activated when the surfaces are submerged for a few
days, detaching and floating to the water's surface and releasing its attractants. After this point, SPLAT BAC Plus
remains buoyant and effective for up to 5 months, considerably longer than the 1–2 week-field life associated
with older Bti/Bsp larvicides. 5) SPLAT BAC Plus contains environmentally safe larvicides and semiochemical
attractants incorporated in an inert matrix composed of food-safe ingredients. To achieve global
commercialization of SPLAT BAC Plus, ISCA Technologies intends to pursue the following Specific Aims: 1)
Obtain the required regulatory approvals to begin sales of SPLAT BAC Plus in the US and begin penetration of
target international markets (e.g., Brazil, Tanzania); 2) Foster consumer support and buy-in via demonstration
trials of SPLAT BAC Plus with targeted distributors of mosquito control products, pest control operators (PCOs),
and mosquito control districts; and 3) Utilize SPLAT BAC Plus to launch a more diversified product line of
mosquito control technologies, designed to conform to the different needs of various mosquito control groups
and consumers, such as varying target species, environmental and safety concerns, and difficulties with
resistance to different control agents.

Public health relevance
Project Narrative This NIH Commercial Readiness Pilot (CRP) project seeks to commercialize a novel product for mosquito control, the first and most critical step in controlling outbreaks of malaria and other mosquito-borne diseases such as West Nile virus, dengue and Zika: SPLAT BAC Plus, a safe, long-lasting larvicide that combines three reduced-risk larval killing agents with attractants for both adult female mosquitoes (inducing preferential egg laying at treated sites) and larval mosquitoes (encouraging feeding on the formulation). Larval control is an effective long-term solution to control mosquito populations, a critical component of vectorial capacity, but use of this tactic is currently hampered by shortcomings in available larvicide products, such as a problematically short field-life and the need to apply quickly after flooding, and by a critical shortage in larvicide active ingredients, particularly after the phase-out of the organophosphate temephos left only four biological modes of action available. By adding an attract-and-kill capacity and incorporating multiple larvicidal AIs into a controlled-release matrix to enable preemptive application, extend their field life, and ensure continued buoyancy and prevent sedimentation, SPLAT BAC Plus will address these limitations in previous larvicides and help to diversify mosquito control programs around the world, which currently rely predominantly on very few chemicals and interventions, leaving them vulnerable to the development of resistance.